MECHANISM OF IMPARIED FOREARM VASCULAR REACTIVITY IN DIABETES MELLITUS

The goal of the study is to test if forearm endothelium-dependent vasodilation is impaired by short-term increase in blood glucose in patients with insulin dependent diabetes mellitus.